TEST SYSTEMS FOR DRUGS AGAINST

The project continues to be devoted to the development of various test systems suitable for testing drugs potentially effective in cancer of the prostate. In the past, several in vivo and in vitro systems utilizing the prostates of dogs, rats and baboons have been utilized in which the activity of 5 alpha-reductase and arginase, deposition of androgens and estrogens and the uptake of labeled zinc were used as indices for the effectiveness of a range of chemotherapeutic agents. Some of the effective agents have been used successfully in the treatment of cancer of the prostate, whereas others, which were effective in animal systems, proved to be too toxic and/or ineffective in human prostatic cancer. Hence, more recently, our major efforts have been and continue to be directed towards the utilization of organ culture of human cancerous and non-cancerous prostatic tissue as a means of testing the effectiveness of various antitumor agents. The indices used include histology, growth rate and a number of biochemical parameters, particularly 5 alpha-reductase activity, labeled zine uptake and the metabolism of androgens. This approach should afford a more direct evaluation of the effectiveness of drugs on human prostatic tumors and may prove to be a more effective and appropriate system than the animal in vivo models. During the last year we have utilized several animal prostatic tumors, both hormone and non-hormone dependent, to test the various drugs as well as their potential in cancer of the prostate. These studies have been and will continue to be performed by administering the drugs in vivo and/or utilizing the tumor tissues in organ culture.